Combined effects of HIV, age and race on inflammation-related brain abnormalitie

PROJECT SUMMARY (See instructions): Although highly-active anti-retroviral therapy (HAART)

Public health relevance
RELEVANCE (See instructions): Reducing age and race-related health disparities in HIV research, and discovering brain biomarkers for early identification of persons at risk for adverse cognitive and motor outcomes in HIV, are high public health priorities. This study addresses both priorities by examining the combined effects of age and race on inflammation-related brain abnormalities in HIV, and associations with cognitive and motor function